Promotion of Hepatocellular Carcinoma by Myofibroblasts

The fact that (i) 80% of hepatocellular carcinomas (HCCs) arise in fibrotic livers and that (ii) chronic injury, inflammation and fibrosis are sufficient to induce HCC suggest that HCC truly represents

Public health relevance
This study will address the role of myofibroblasts in hepatocellular carcinoma (HCC) with a particular focus on